Long-term systemic consequences of type 2 skin inflammation on epithelial stem cells

Project Summary/Abstract
Modernization has been accompanied by a marked rise in disorders of allergic inflammation. These
diseases are frequently borne by epithelial barrier tissues such as the skin, lung, and gut, which provide essential
protection against the inflammatory stresses of the outside world. An emerging hallmark of barrier inflammation
is the ability of these tissues to durably adapt to prior experiences, enhancing future responses against a broad
range of stressors. The Fuchs Lab and others have revealed that long-lived epithelial stem cells (EpSCs), which
replenish and repair their tissues throughout life, are key proprietors of these barrier adaptations in the context
of type 17 inflammation, generally associated with extracellular pathogen responses. Conversely, how EpSCs
adapt to allergic “type 2” inflammatory exposures remains a poorly understood and urgent unmet health need.
To address this critical problem, I seek to use the prevalent epithelial alarmin thymic stromal
lymphopoietin (TSLP) as a driver to uncover how type 2 skin inflammation impacts the long-term functional
responsiveness and epigenetic state of EpSCs. My preliminary work reveals that transient TSLP-driven type 2
skin inflammation endows resident EpSCs with long-term increased stemness in vitro, and that inflammation-
experienced skin retains a concurrently heightened ability to heal wounds in vivo. Surprisingly, I discovered that
this lasting hyperresponsiveness extends beyond localized sites of inflammation, as even distal EpSCs and skin
maintain comparably enhanced stemness and wound repair upon resolution, despite having never seen
pathologically evident inflammation. With these data in hand, I will define the specific cell-intrinsic mechanisms
that distinguish TSLP-driven inflammatory memory in both local and systemic contexts, and will interrogate the
niche signaling that acts on EpSCs to establish cellular and tissue-level hyperresponsiveness in each. Lastly,
given that my findings thus far could help explain the puzzling frequent interlinking of atopic inflammation in the
skin and airway, I will determine whether TSLP-driven skin inflammation may have parallel cross-tissue effects,
and alter the long-term functionality and epigenetic state of airway EpSCs. If successful, my findings will reveal
important new insights into how allergic inflammation can shape long-term, organism-wide fitness beyond
antigen-specific immune sensitization and memory, and add a molecular explanation for long-standing human
pathologies that could advance treatment strategies.

Public health relevance
Project Narrative The skin is continually exposed to the inflammatory stresses of the outside world. Following transient inflammation, the long-lived epithelial stem cells that maintain this barrier can retain lasting epigenetic memories that markedly heighten future responses to stress. This proposal will explore how allergic type 2 inflammation in skin specifically influences the long-term functionality of epithelial stem cells, both locally within sites of inflammatory pathology and systemically across the skin and airway epithelia.